Preparing Patient-Caregiver Dyads with Parkinson's Disease for End-of-Life Decision Making

Project Summary/Abstract
The K23 application describes the background and experience of Dr. Jiayun Xu, PhD, RN, and her research
and training plan to become an independent nurse researcher in the field of dyadic advance care planning
interventions among persons with serious illness and their families (e.g. Parkinson’s disease). The overall goal
of the K23 is to gain experience in designing and testing clinical trials, learn about different models for advance
care planning (ACP) facilitation, and gain skills to conduct advanced dyadic and longitudinal analysis of data. A
comprehensive training plan has been developed with an interdisciplinary mentorship team with the following
training goals: (1) develop competency in the design and delivery of dyadic ACP communication interventions
among persons with Parkinson’s disease and their caregivers; (2) acquire expertise in ACP communication models
that can be applied to persons with Parkinson’s disease and their caregivers; and (3) develop skills in analyzing
complex dyadic data using longitudinal and multilevel statistics. The training plan includes intensive one-on-
one mentorship, coursework/workshops, formal training on clinical trials and advance care planning facilitation,
and independent studies on advance care planning and longitudinal statistics with mentors. The purpose of
the K23 project, is to develop, refine, and test the feasibility of a novel dyadic ACP intervention tailored to the
unique needs of people with Parkinson’s disease and their caregivers. The specific aims are: (1) to identify the
dyadic advance care planning needs for Parkinson’s disease, (2) develop and refine dyadic Parkinson’s
disease-specific ACP materials, and (3) pilot test the dyadic Parkinson’s disease-specific ACP materials with
an established intervention – PREPARE – for feasibility and acceptability. Results will lead to a R01 application
for translating the intervention from pilot testing to a fully powered randomized control trial.

Public health relevance
Project Narrative Persons with Parkinson’s disease and the family members who care for them are often unprepared to make difficult end-of-life medical decisions. Earlier end-of-life conversations between persons with Parkinson’s disease and their family members are needed before communication and cognitive difficulties become severe. In this study, we will develop and pilot test a novel dyadic intervention to help persons with Parkinson’s disease and their family members have end-of-life conversations.